Administrative Core

PPG ADMINISTRATIVE CORE C SUMMARY
The Administrative Core (Core C) will provide strong centralized scientific and administrative leadership to
facilitate synergistic interactions between the three Projects and three Cores of this P01 via these major services:
Professional Direction for the aggregate PPG, Communication and Coordination of PPG-related activities,
Organization of Program Project Meetings, and Biostatistical Support for Component Project Investigators
and Core Leaders. Dr. Richard Peek, Principal Investigator, has primary responsibility for all aspects of the
Program and the Administrative Core. He will be aided by the Project Leaders, Core Directors, members of the
Scientific Advisory Boards, and administrative personnel. The administrative staff of the Core will oversee all
annual budgets, monitor expenses, provide monthly statements of financial activities, and maintain the secure,
dedicated PPG website which contains information describing the overall P01 as well as contact information and
links to the home pages of the individual Project Leaders and Core Directors. This website also includes links to
Departments, Divisions, and Centers at Vanderbilt that support investigators in this P01, including the Divisions
of Gastroenterology and Infectious Diseases, the Department of Pathology, Microbiology and Immunology, the
NIDDK-supported Vanderbilt Digestive Diseases Research Center, the NCI-supported Vanderbilt GI SPORE,
the Mass Spectrometry Research Center, the Vanderbilt Institute for Infection, Immunology, and Inflammation
led by Internal Advisor Eric Skaar, and the Vanderbilt Translational Pathology Shared Resource. We have also
included links to important resources exogenous to Vanderbilt, including the National Cancer Institute and a link
to Box, Vanderbilt’s secure web-enabled file distribution site, to facilitate the transfer of large data sets among
the Project and Core Leaders. The website includes a REDCap-generated list of publications supported by this
P01 over the current funding period, which is updated on a monthly basis by one of the Administrative Assistants
for Core C, Ms. Myra Harris. Biostatistical analysis and interpretation are provided to all Program Project
participants by the Administrative Core C Biostatisticians and, due to exciting new discovery-driven technologies
incorporated within each Project, a new Bioinformatician (Qi Liu) and a new Biostatistician (Dan Ayers) have
now been added as Key Personnel. All Program-related meetings will be scheduled through this Core, including
monthly meetings of Project and Core leaders to evaluate and monitor productivity, allocate core usage and
Program resources, and discuss future directions. A bi-monthly scientific meeting allows investigators to present
current data, identify problems, and discuss solutions. Arrangements for the combined Scientific Advisory Board
meetings, planned for every 2.5 years of the Project period, as well as generation of materials to be reviewed,
will be handled through the Administrative Core. Finally, this Core will prepare, generate, and assemble materials
required for the annual progress reports and will ensure that all additional NIH and institutional reporting
requirements concerning the Program Project’s activities are completed in a timely manner.

Public health relevance
PPG ADMINISTRATIVE CORE C NARRATIVE Administrative Core C will facilitate all of the activities required to collaboratively identify bacterial, host, and dietary factors that influence gastric carcinogenesis.